Effects Of Chemopreventive Agents On Biomarkers Related To Lung Tumorigenesis: Al

This Task Order is directed towards identification of changes in patterns of gene expression associated with induction of lung cancer which may be useful as biomarkers.